32nd Fungal Genetics Conference

The 32nd Fungal Genetics Conference will be held at the Asilomar Conference Center, March 12-17, 2024. This
biennial conference is one of the premiere international meetings for fungal biologists. More than 900 US and
international scientists and students are expected to attend. Goals of this biennial meeting are 1) to promote the
dissemination of the latest research on all aspects of the biology of fungi with a focus on filamentous fungi and
2) to promote communication and collaboration between Medical Mycologists and those working with other
fungal systems. This conference has brought many researchers into the field of Medical Mycology over the years.
Understanding the biology of fungi and their host interactions is critical to, and has been successful in, the
development of new antifungal therapeutics. The 32nd FGC will have four plenary sessions, 28 concurrent
sessions over 4 days, and three poster sessions. The plenary topics are: Functional genomics illuminates
foundational biology and evolution of fungi, Multilevel regulatory circuits to understand fungal metabolism,
Underneath, within, and around: the biology of pathogenic and symbiotic fungi, and interactions of fungi with all
members of the biosphere. The 28 concurrent sessions are divided into 7 areas: Pathology, Molecular Ecology,
Gene Regulation, Morphology and Development, Evolution, Biotechnology and Tools and Novel Topics. Medical
mycology is well represented at the conference with plenary talks on Candida, Aspergillus fumigatus,
Cryptococcus, Coccidioides, and Mucor circinelloides and concurrent sessions on Understanding fungal
pathogenesis through high-throughput genomics, Antifungal Resistance, Development, and Mechanism of
Action, Biofilms, biocontrol and disease prevention by genome engineering, Understanding and controlling
antifungal resistance: new technologies and approaches as well as several other that will include talks on
medically relevant fungi (See program for more detail). The FGC places a strong emphasis on the participation
of young scientists and students, particularly those from underrepresented groups. Many have their first
opportunity to present their research at a major international conference either through the poster sessions or
via concurrent sessions where half of the speakers in each session are chosen from submitted abstracts for a
total of 112 talks. Funds are requested to help defray travel and participation costs of students, postdoctoral
researchers, and some early career scientists, and will be distributed on a need basis.

Public health relevance
The Fungal Genetics Conference brings together fungal biologists working on most major fungal systems and promotes communication and collaboration between those working on fungi related to human health including Medical mycologists, working on fungi that cause diseases of people and those working on food security as well as others working on plant pathogens, saprobes and symbiotic fungi. This interaction allows students interested in mycology to find and pursue opportunities for research careers in Infectious Diseases and other areas towards reducing the impact of fungi on human health. Fungi also serve as important model systems to understand basic processes in cells that when altered result in diseases of people based on the presence in fungi of many genes and metabolic and regulatory pathways relevant to those altered in people impacted by these diseases.